Pilot Testing an Intervention to Enhance Coping and Increase Mental Health Help-seeking Among Transition-Age Youth in Foster Care

Project Summary/Abstract
Young people transitioning from the foster care system have elevated risk for a range of mental health diagnoses that
for many are exacerbated by psychosocial coping difficulties, sparse support networks, and service disengagement. This
population is less prepared to cope with mental health challenges and more likely to have negative perspectives on help-
seeking, increasing the risk of unmet treatment needs as service use rapidly declines following the exit from foster care.
Our long-term goal is to deploy a scalable secondary prevention program that leverages existing foster youth transition
services to improve mental health functioning and service use before and after exiting foster care. Our short-term
objective is to remotely test a transdiagnostic group intervention called Stronger Youth Networks and Coping (SYNC) that
targets cognitive schemas influencing stress responses, including mental health help-seeking and service engagement,
among foster youth with behavioral health risk. SYNC aims to increase youth capacity to appraise stress and regulate
emotional responses, to flexibly select adaptive coping strategies, and to promote informal and formal help-seeking as
an effective coping strategy. SYNC results from intervention development to design a novel program using evidence-
based cognitive change methods, including adapting the Coping Effectiveness Training (CET) curriculum for foster youth.
SYNC is designed for delivery by service providers in federally-funded Independent Living Programs (ILPs) accessed by
most foster youth in the US. Initial feedback from foster youth, service providers, and our advisory panel confirmed the
acceptability of SYNC curriculum topics (e.g., stress and coping, navigating services) and program strategy (e.g., groups
co-facilitated by “near-peer” young adults with foster care and mental health care experience). The proposed aims will
establish whether the 10-module program engages the targeted proximal mechanisms with a signal of efficacy on
clinically-relevant outcomes, and whether a fully-powered RCT of SYNC is feasible in the intended service context. Our
first specific aim is to refine our SYNC curriculum and training materials, prior to testing SYNC in a remote single-arm trial
with two cohorts of 8-10 Oregon foster youth aged 16-20 (N=16). Our second aim is to conduct a remote two-arm
individually-randomized group treatment trial with Oregon foster youth aged 16-20 with indicated behavioral health risk
(N=80) to examine: (a) intervention group change on proximal mechanisms of coping self-efficacy and help-seeking
attitudes, compared to services-as-usual at post-intervention and 6-month follow-up: and (b) association between the
mechanisms and targeted outcomes, including emotional regulation, coping behaviors, mental health service use, and
symptoms of depression, anxiety, and PTSD. Our third aim is to refine and standardize the intervention and research
protocol for an effectiveness trial, including confirming transferability with national stakeholders. The demonstration of
target engagement with initial evidence of efficacy, plus standardized intervention materials and a feasible research
protocol, will prepare us for an effectiveness trial (R01) of a model that is expected to be widely transferable for
implementation across the country, and one that can ultimately be adapted for other youth service settings (e.g.,
juvenile justice) and subgroups (e.g., LGBTQ, youth of color), expanding long-term public health impact.

Public health relevance
Project Narrative Young people transitioning from the foster care system are at elevated risk for a range of mental health diagnoses, but they are often less prepared to manage mental health challenges and more likely to have negative perspectives on help- seeking, increasing the risk of unmet needs as service use rapidly declines following the exit from foster care. We are pilot testing an indicated prevention intervention to improve coping self-efficacy and help-seeking attitudes in ways that lead to adaptive functioning, including social support-seeking and mental health treatment engagement. Our remotely- delivered group-based intervention approach is a broadly scalable enhancement to existing foster youth transition services, and is likely transferable to similar service-involved youth populations during the transition to adulthood.